Developing a multi-component vaccine harnessing potent antibody and cellular responses against the blood-stage of Plasmodium falciparum

PROJECT SUMMARY
The malaria parasite P. falciparum continues to cause significant morbidity and mortality, with 228 million clinical
cases and 405,000 deaths in 2019. With progress towards controlling malaria stalling in many high burden
countries and the continuing spread of drug resistant parasites, an effective malaria vaccine is urgently needed.
RTS,S, a vaccine currently under implementation, has modest efficacy (~30%) and immunity waning rapidly.
Importantly, this vaccine does not target the disease-causing forms of the parasite. An efficacious vaccine
targeting Plasmodium blood-forms is required to reduce parasite burden, clinical disease and sequelae to severe
disease. Our proposal aims to address this gap by developing a multi-modal P. falciparum vaccine targeting the
blood-stage parasite and evaluating its efficacy using a relevant primate model of human malaria. We will build
this multi-modal vaccine by incorporating two vaccine candidates with distinct effector mechanisms. The
individual components have been tested rigorously and reproducibly in pre-clinical efficacy models. The first is
a sub-unit vaccine candidate (AMA1-RON2L complex), designed to enhance antibody quality by increasing the
proportion of neutralizing antibodies targeting AMA1. Using a structure-based approach we have now designed
this subunit vaccine to cover AMA1 polymorphisms and generate strain-transcending, neutralizing antibodies.
The second is a whole blood-stage parasite vaccine that induces a strain-transcending, anti-parasite response
through direct cell-mediated killing. This multi-modal vaccine will be formulated with a novel cationic liposomal
adjuvant that potently activates both the humoral and cell-mediated arms of the immune system, thereby
providing a human-compatible adjuvant platform. We will perform dosing studies to optimize the P. falciparum
multi-component vaccine in mice and evaluate impact of biological sex on the vaccine-induced immune
response. We will also assess memory B cell and T cell responses induced by the multi-modal P. falciparum
vaccine (Aim 1). Next, we will assess immunogenicity and protective efficacy of this multi-modal vaccine against
homologous and heterologous P. falciparum in Aotus nancymaae and evaluate the persistence of the immune
responses using a delayed re-challenge model (Aim2). Lastly, we will use validated immunological assays and
apply cutting-edge technology (single-cell RNASeq) to help inform our understanding of immune correlates of
protection. The major deliverable of this project will be a novel, pre-clinically validated, multi-modal P. falciparum
blood-stage vaccine in a human-compatible liposomal adjuvant that can be progressed towards clinical trials.

Public health relevance
PROJECT NARRATIVE Malaria is a life-threatening disease caused by Plasmodium parasites and the development of an effective malaria vaccine is key to shifting the fight against malaria towards elimination. This project will develop and evaluate the efficacy of a multi-modal vaccine against blood-stage parasites formulated with a novel human- compatible liposomal adjuvant, using a non-human primate model of human malaria. The rational inclusion of the two parasite components is expected to result in strain-transcending neutralizing antibodies induced by a structure based AMA1-RON2L vaccine that will synergize with a broad cellular response induced by the whole blood-stage antigens to maximise control of the blood-stage parasite and confer protection against P. falciparum blood-stage infection.